Doctoral Training/Alcohol-Related Health Services Research

Project Summary/Abstract
The Doctoral Training Program in Alcohol-Related Health Services Research at the Heller School at
Brandeis University prepares students to become scholars in alcohol-related health services research for
teaching and research careers in universities, government agencies, research organizations and major service
delivery systems. It has been an integral part of the Ph.D. in Social Policy program at the Heller School since
its beginning in 1994. We focus on how organization, management, financing and payment make a difference
in the effective delivery of prevention, treatment and recovery services for alcohol problems. We specifically
focus on how these factors intersect with how disparate and vulnerable populations face unique barriers to
these services. In this competitive renewal, which requests nine predoctoral training slots for the next five-
year cycle, the successful leadership and program structure and content of the current multi-disciplinary
training program is maintained. We include an explicit plan to enhance the diversity of the applicant pool.
Typically, three new students enter the program each year and are supported for three years.
The educational goals of the training program function at the intersection of three domains: theory,
applied research, and policy. A rigorous multi-disciplinary education that includes several alcohol courses in
the behavioral health concentration, intensive discipline-based mentoring to guide trainees as they develop
and conduct dissertations that incorporate alcohol topics, and hands-on alcohol-related research experience
combine to provide these trainees with the skills and knowledge needed to be successful alcohol-related
health services researchers. The doctoral program at the Heller School constitutes the foundation of the
educational program of the alcohol-related services research training program, which is housed in the
behavioral health concentration. It adds the specialization in services research and policy analysis in the field
of alcohol use and alcohol use disorders. It is sequenced to provide broad substantive knowledge regarding
the evolution of and current issues in major policy areas relevant to alcohol use disorders, advanced training in
the principles of research design and statistical reasoning, experience in the conduct of applied research, and
directed study through the dissertation on a topic related to alcohol services. Collaborations with local research
organizations and universities expand research opportunities.
We are committed to recruiting a diverse pool of trainees who have real-world experience in a variety of
settings, who bring a depth and breadth of knowledge to the Heller School experience and to research and
social policy analysis, and who are able to link their research foundation with real-world service delivery. The
progress and commitment of the current and former trainees of the Heller Doctoral Training Program in
Alcohol-Related Health Services Research provide evidence for success.

Public health relevance
Project Narrative Alcohol-related services research can lead to improved systems for prevention, treatment and recovery services, thereby enhancing quality and reducing the adverse consequences of alcohol use disorders. Training the next generation of alcohol services researchers continues to be crucial because of the continued magnitude of alcohol problems in the US, the complexity of delivery systems, and the rapid changes in the overall healthcare environment.